HOME VISITING CAREER TRAJECTORIES

The goal of the Home Visiting Career Trajectories project is to examine the state of home visiting careers to understand how people enter the field, the perceived and actual pathways for professional advancement and tenure, and reasons for field attrition. This work aims to address the paucity of data on the home visiting workforce that can be used to learn how to best recruit and retain high quality staff. The project has two purposes. First, it will provide information on the state of the home visiting sector and the career trajectories of home visitors and recommendations on strategies to build a pipeline of high-quality home visitors and supervisors. Second, it will provide information on the professional development system that supports early childhood home visiting, including training and technical assistance supports. To accomplish these goals, the research team will access pre-existing administrative and survey data and collect new data as necessary. Urban Institute was awarded this contract. This project is being led by the Administration for Children and Families in collaboration with the Health Resources and Services Administration.